The Role of Intraoperative Transesophageal Echocardiography During Isolated Coronary Artery Bypass Graft Surgery

PROJECT ABSTRACT
Transesophageal echocardiography (TEE) is an ultrasound-based cardiac imaging procedure frequently used
to facilitate informed surgical decision making and manage intraoperative complications during the quarter
million cardiac surgeries performed in the US each year. And yet, there is no randomized evidence to support
the use of intraoperative TEE in any type of cardiac surgery. This lack of randomized evidence is particularly
problematic in isolated coronary artery bypass graft (CABG) surgery because observational comparative
effectiveness studies are conflicted regarding the association between improved postoperative outcomes with
(vs without) intraoperative TEE. Complicating matters, TEE is an invasive procedure where its unconfirmed
clinical benefits may not outweigh its confirmed risks of gastroesophageal injury. The questions surrounding
the unclear clinical efficacy, unknown real-world effectiveness, and undefined risk-benefit ratio of intraoperative
TEE during isolated CABG surgery is a critical evidence gap with clinical equipoise that has resulted in
widespread practice pattern variability and a near 50/50 split in TEE (vs no TEE) intraoperatively. Thus, the
overall objectives of this K23 research will leverage this existing clinical equipoise and practice pattern
variability to generate the required foundational data necessary to inform a future, multicenter, randomized
controlled trial (RCT) that could resolve the questions surrounding the clinical efficacy, effectiveness, and risk-
benefit ratio of intraoperative TEE use (vs lack of use) during isolated CABG surgery. To that end, three aims
will test the central hypothesis that among a routine isolated CABG surgery population (i.e. a population
suitable for randomization given the absence of valve disease), the treatment effects of intraoperative TEE on
postoperative clinical outcomes after isolated CABG surgery will vary among subgroups (aim 1) and that
randomizing routine isolated CABG surgery patients to either default (i.e. obligatory) or as-needed (i.e. backup)
intraoperative TEE will garner adequate participation by stakeholders (aim 2), and demonstrate enough
practical feasibility in a single-center, pilot RCT conducted at the Candidate’s institution (aim 3), to accomplish
on a larger scale in a future, multicenter RCT. The information gained from completion of these three aims will
provide the preliminary data required to inform subsequent, multicenter clinical trial(s) comparing perioperative
clinical outcomes among routine isolated CABG surgery patients randomized to default vs as-needed
intraoperative TEE. In combination with a structured course of mentoring, and a research training plan heavily
focused on the how to plan, design, and conduct randomized clinical trials, this K23 will be the foundation for
the Candidate’s progression toward becoming a leading clinical trialist and comparative effectiveness
researcher dedicated to improving clinical outcomes in the cardiac surgical patient population.

Public health relevance
PROJECT NARRATIVE The lack of definitive evidence (prospective randomized or retrospective observational) to support (or refute) the use of intraoperative transesophageal echocardiography (TEE) during isolated coronary artery bypass graft (CABG) surgery has led to widespread practice pattern variability and a near 50/50 split in TEE (vs no TEE) intraoperatively – an evidence gap with clinical equipoise. This study aims to leverage this existing practice pattern variability and clinical equipoise to generate the required foundational data necessary to inform a future, multicenter randomized controlled trial (RCT) that could resolve questions surrounding the efficacy, effectiveness, and risk-benefit ratio of intraoperative TEE during isolated CABG surgery. These findings will be critically important for health policy efforts to reduce variability, standardize intraoperative care, and improve perioperative outcomes among cardiac surgery patients undergoing isolated CABG surgery.